Profiling the human dentate gyrus across the lifespan with spatially-resolved transcriptomics

PROJECT SUMMARY
The hippocampus plays a well-established role in learning and memory across the lifespan, with
developmental and plasticity-related gene expression changes observed from infancy through old age. Due to
its structure and circuitry, the region has been linked to a number of critical behavioral functions. Hippocampal
neurons are organized in densely packed layers according to dendrite-axon polarity, and synaptic connections
within the hippocampus are major sites of structural and functional plasticity across the lifespan that regulate
critical functions related to learning, memory, mood and stress regulation. Many important plasticity-related
transcripts are localized to the dendritic compartment, and their transcription, transport out of the nucleus, and
translation within the dendritic compartment is tightly regulated, both developmentally and by neuronal activity.
Additionally, despite extensive characterization of the functional importance of postnatal neurogenesis in
rodent dentate gyrus (DG), indisputable evidence of adult neurogenesis in the human DG (hDG) remains
elusive and its persistence throughout the lifespan remains controversial. Recently, cell-type specific molecular
profiles of the human hippocampus in adults and across the lifespan have been described, using single-
nucleus RNA sequencing (snRNA-seq); however, these resources lack spatial resolution within the
hippocampus and lose transcriptomic information from the cytosolic compartment. Given the tight correlation
between spatial structure and function in HPC, and the particular importance of transcripts localized to the
synaptic compartment, molecular profiling technologies with the capacity to address these gaps in our
knowledge are needed. Thus, we propose the generation of spatially-resolved, transcriptome-wide gene
expression profiles in hDG across the lifespan, from neurotypical donors in four age groups across the human
lifespan (infant, teen, middle-age, and elderly). Data will be compiled into a user-friendly browser as a
community resource. Expert neurobiologists will perform manual annotations of canonical subfields, while
biostatisticians will apply unsupervised clustering algorithms to identify novel spatial domains. We will then
compare gene expression across the lifespan to identify developmentally- and spatially-regulated gene
expression. We will validate the cellular expression patterns of specific novel gene markers by performing
smFISH in our donor cohort. This approach will facilitate refined annotation of spatial gene expression patterns
in the human hippocampus, and contribute to understanding neurodevelopmental and neurodegenerative
disorders by identifying clinical associations with spatially-defined cell populations that can be targeted for
prevention and treatment.

Public health relevance
PROJECT NARRATIVE The hippocampus is a region of the brain with a unique spatial organization that is highly associated with learning, memory and cognitive function across the lifespan. In this application, we will generate spatial transcriptomic maps in the human hippocampus from infant, teen, adult and elderly donors. This data will identify subfield-specific gene expression patterns to better understand the processes of human growth and development.